CLINICAL SYNDROMES ASSOCIATED WITH MTDNA POINT MUTATIONS

To characterize the cognitive and behavioral deficits associated with mtDNA point mutations and correlate them with cerebral energy metabolism assessed by NMR spectroscopy. We will also attempt to establish a sensitive screening test for patients with Mitrochondrial diseases based on the calcium-buffering capacity of cultlured skin fibroblasts.